Cardiovascular Structure and Function in the Mucopolysaccharidoses

Cardiovascular disease (CVD) is the leading cause of death in the world despite public health emphases upon
treatment of hyperlipidemia, hypertension, and diabetes mellitus. Cardiovascular manifestations are also a
leading cause of mortality in two inherited conditions, Mucopolysaccharidosis (MPS) types I and IVA. These rare
diseases invite further investigation because affected individuals accumulate large quantities of
glycosaminoglycans (GAGs). While GAGs are normal proteoglycan components of healthy cardiac valves,
arterial parenchyma, and endothelial glycocalyx, excess quantities contribute to CVD pathogenesis but via poorly
understood pathomechanisms. We present three interrelated, yet parallel aims: a clinical, a hybrid
clinical/preclinical, and a preclinical trial which leverage our combined clinical and translational research
expertise. This project examines human and murine MPS I and IVA to robustly probe the relationships between
derangements in cardiovascular GAG content and cardiovascular structure and function. Aim 1 of this project
prospectively assesses cardiac and arterial structure and function in a large cohort of MPS I and IVA patients,
rigorously comparing with an equally large cohort of healthy matched controls to establish a MPS CVD natural
history. Results from this aim will provide a clinical basis for evaluation of therapies targeting MPS cardiovascular
symptoms. Aim 2 of this proposal will define and validate prognostic biomarkers of both human and murine MPS
CVD. Results of these studies will greatly expand the understanding of proteoglycan function in cardiovascular
health and disease. Aim 3 of this proposal will utilize the foundations previously established to evaluate efficacy
of click-xyloside modulators of GAG biosynthesis and an inhibitor of elastin proteolysis to mitigate murine MPS
cardiovascular manifestations. The result of these studies will determine preclinical efficacy of therapeutic
compounds and inform future human therapeutic trials. The long-term goal of this study is to understand
roles of cardiovascular GAGs and proteoglycans, validate biomarkers, and develop treatments to stop
progression in MPS cardiovascular pathology.

Public health relevance
Project Narrative Cardiovascular complications are the second leading cause of mortality for two inherited conditions, mucopolysaccharidosis (MPS) types I and IVA; importantly, the reasons for these complications are not well understood, and existing therapies do not treat these symptoms. We believe that the MPS-caused buildup of highly modified sugars called glycosaminoglycans within cardiovascular structures promotes inflammation and breakdown of important proteins within the heart and blood vessels, leading to disease and dysfunction. Our project’s goals are to first establish a clear understanding of how cardiovascular symptoms and markers evolve over time in patients with mucopolysaccharidosis I and IVA; then, we will use animal models of these disorders to evaluate new treatment approaches with three candidate compounds aimed to address MPS cardiovascular symptoms.